SOX4-Mediated Transcription Program in Esophageal Adenocarcinoma

ABSTRACT/SUMMARY
The incidence of esophageal adenocarcinoma (EAC) has increased 600% in the last three decades. Treatment
options, however, are limited, especially for EACs diagnosed at the late stages. Thus, identifying new
therapeutic targets is necessary to improve the overall dismal 5-year survival rate of less than 15%. This
proposal is an integral part of a P01 Program focused on identifying mechanistic vulnerability while providing
potential therapy for EAC treatment. This application will directly address novel molecular mechanisms that
control the transition from stem cells to adenocarcinoma-initiating cells and whose inhibition has the potential
to block EAC development. Prolonged reflux where acidic bile salts abnormally refluxate into the lower
esophagus is closely associated with the incidence of Barrett’s esophagus (BE, also known as intestinal
metaplasia), an entity considered as the precursor to EAC. Studies from our lab and others have shown that
malignant transformation of stem/progenitor cells is a critical mechanism that occurs during esophageal cancer
initiation. In the case of EAC, we have identified that the novel transitional basal cells (TBCs) located at the
esophageal-gastric junction (EGJ) are able to generate Barrett’s esophagus upon Cdx2 overexpression. Our
preliminary data show that EAC develops at the EGJ following prolonged Cdx2 overexpression and bile acid
reflux. The genetic regulatory program that drives stem cell transformation and cancer maintenance, however,
remains elusive. We found that SOX4 transcription factor is highly expressed in mouse EAC models and
human EAC biopsies. Decreased levels of SOX4 protein are associated with reduced cancer growth. Using a
combination of RNA-Seq, ChIP-Seq, and targeted RNAi screening, we identified EGFR and ELF3 as potential
downstream targets mediating SOX4 function in tumor development. Therefore, we hypothesize that SOX4 is
critical for EAC initiation and maintenance and that suppressing SOX4-centered signaling can be
utilized for therapeutic gains in EAC treatment. Our studies integrate well with other projects in this P01
and we will test the roles of APE1 redox function and isolevuglandin protein adducts in regulating SOX4. We
have designed three aims to test this hypothesis: (1) To determine the role of SOX4 in EAC development; (2)
to test the hypothesis that SOX4 transcriptionally regulates EGFR and ELF3 in EAC; and (3) to determine the
therapeutic role of SOX4 inhibition in EAC treatment. We will use multiple mouse models (e.g., SOX4 gain-
and loss-of-function) combined with organoid and patient-derived xenograft models to address these aims and
test two candidate drugs identified through an unbiased screen. Our studies will provide novel insights into the
cellular and molecular mechanisms underlying the EAC’s initiation and progression, facilitating the
development of novel treatments of deadly EAC.

Public health relevance
Narrative The incidence of esophageal adenocarcinoma (EAC) has increased 600% in the last three decades, and treatment options are limited. This proposal will identify the mechanisms underlying the initiation and maintenance of EAC relevant to stem cell regulation. The knowledge gained will be used for comprehensively identifying new therapeutic targets and medications for treating the disease.